Otolaryngology Training in Immunology, Virology and Molecular Biology

PROJECT SUMMARY/ABSTRACT
The education of clinician-scientists is of paramount importance to the field of Otolaryngology. The need for
interfaces between science and medicine, the importance of clinicians that value scientific research, and the
increased importance of evidence-based medicine in health care all argue for research training of
physicians. Moreover, the impact of immunological mechanisms in many ENT diseases has received
increased attention in the past decade, with an increase immune/inflammatory therapeutics in our field.
Immunotherapy has proven to be highly effective in several forms of cancer. Yet Otolaryngology remains
behind many other areas of medicine in immunology research. As an example, the area of innate immunity
mediated by pathogen receptors has seen a dramatic expansion in the broader field of immunology and
infectious diseases over the past 20 years, and the head and neck represent a major pathogen interface.
However, only within the last few years has an increase in innate immune research been seen in our field.
The availability of molecular methods has transformed research in immunology and other areas of
biomedicine, molecular therapies are in active development, and the era of genomic medicine has arrived.
Clinician-scientists well trained in molecular biology are therefore needed. Finally, research into viral
diseases could not be more relevant at the current time. Over the past 30 years, UCSD Otolaryngology has
expanded its immunology, virology and molecular research, resulting in an established cadre of scientists.
These investigators provide a fertile training ground for clinicians who wish to pursue these arenas of
research, to provide ENT with well-trained clinician-scientists. We propose to continue our clinician-scientist
resident research training program under the R25 mechanism. Our program addresses the major barriers to
research by clinicians by providing training in: 1) experimental design and scientific techniques; 2) research
collaboration and teambuilding; 3) grant and scientific manuscript writing; 4) managing the conflict between
clinical work and research; and 5) preparation for academic medicine. The trainees for this program will be
selected from MD's who wish to pursue eighteen months of research training during their Otolaryngology
residency, consisting of the R25 year and additional periods of research training embedded in clinical
training. Trainees from underrepresented groups will be actively sought. Trainees will receive advanced
basic science, translational or clinical research training in the application of advanced immunology, virology
and molecular biology methods to research problems within the NIDCD arena. Research training will extend
throughout residency, to provide continuity and avoid a significant training gap. Trainees will also receive
instruction in research ethics, methods to ensure data quality and reproducibility, responsible conduct of
research, and the preparation of initial review board applications. Finally, we will encourage choice of a
career including research with specific education.

Public health relevance
PROJECT NARRATIVE Relevance to Public Health: Training physicians in Otolaryngology to perform research is of critical importance to the future of the field as well as patient care. Only through research that is performed in a rigorous manner by highly trained physician-scientists will diseases be understood and new treatments developed and validated. The proposed training will prepare Otolaryngologists for careers in that include high-quality research.